Strengthening the Quantitative Pipeline for Multidisciplinary Trauma Research in Cameroon

PROJECT SUMMARY/ ABSTRACT
Trauma is a leading cause of death and disability in Sub-Saharan Africa (SSA), particularly in Cameroon, where
a higher burden of injury is reported compared to similar settings in the region. Injury research focused on
prevention and improvements in trauma care, such as trauma Quality improvement (QI), have led to significant
reductions in the burden of injury in high-income countries. Yet, there remain critical gaps in the current trauma
research infrastructure in SSA due to limited training opportunities. The Sustainable Trauma Research,
Education, and Mentorship Program (STREaM) will seek to fill this gap, building on an existing long-term
partnership between the University of California and the University of Buea (Buea) to provide innovative training
to Cameroonian post-graduate candidates with a focus on novel, cutting edge quantitative tools. STREaM
Cameroon program will aspire to establish a cadre of graduate trainees with multidisciplinary expertise in Injury
prevention and control, quality improvement, and quantitative methods that can address limitations posed by the
time-dependent, dynamic, and incomplete nature of trauma-related data. The program will leverage recent
advances in research methodologies, such as machine learning and implementation science, that are particularly
suited to trauma research. STREaM Cameroon aims to accomplish the following objectives:1) Train a
critical mass of multidisciplinary scientists in trauma research through MPH, PhD, and post-doctoral pathways
who will form the foundation for an Injury Center at the Buea; 2) Develop and implement a combination of short,
medium, and long-term quantitative and trauma research curricula co-taught by U.S. and Cameroonian faculty
to sustainably strengthen existing offerings at the Buea; 3) Provide mentored research opportunities for trainees
to apply quantitative skills to trauma QI projects utilizing the partnership’s existing research and data collection
infrastructure in Cameroon; and 4) Integrate trainee scholars into a robust scientific network through existing
international organizations and the creation of a Cameroonian Trauma Network to serve as an ongoing
community of practice. During the five-year program, a total of 2 post docs, and eight PhD and Master’s level
students per year will be trained using a team mentoring approach. Master’s and PhD students will take part in
online courses throughout their training, administered through the University of California Berkeley and University
of California San Francisco’s Clinical and Translational Science Institute. All students will participate in mentored
research. Additionally, post-docs will spend one semester at Berkeley receiving in-person training to prepare
them for faculty positions at Buea. Upon completion of the STReaM program, graduates will successfully engage
in innovative, evidence-based research to improve the quality of trauma care and reduce the burden of injury
among vulnerable populations in SSA. STReaM Cameroon graduates will thus be trained and equipped to
mentor the next generation of scientists in trauma research, playing a critical role in influencing healthcare
practices and policy locally and internationally.

Public health relevance
PROJECT NARRATIVE Trauma is a leading cause of preventable death and disability in the United States, particularly in rural “trauma deserts” or disaster-response settings where access to timely trauma care is resource-constrained. Our U.S.-Cameroon collaboration aims to identify efficient, cost-conscious systems intervention to improve trauma care in austere settings, but this relies on a critical mass of trained cohort of scientists necessary to generate evidence and implementation strategies directly applicable to improving U.S. trauma systems. By training Cameroonian investigators in trauma research and implementation science, STREaM Cameroon supports the development of scalable, cost-effective approaches to trauma care that can improve outcomes for vulnerable populations in the United States.